Staphylococcus aureus extracellular vesicles: host-pathogen interactions

Project Summary/Abstract
Staphylococcus aureus is an important bacterial pathogen that provokes a diverse range of human diseases,
ranging from mild skin lesions to invasive and life-threatening infections. The virulence traits that characterize
S. aureus include surface adhesins and glycopolymers, as well as secreted proteins, such as cytolysins,
superantigens, and proteases, many of which play vital roles in immune evasion. S. aureus also produces nano-
sized, spherical, bilayered, extracellular membrane vesicles (EVs) with distinct biologic activities. The production
of EVs represents a secretory pathway common to mammalian cells, fungi, and bacteria that allows for cell-free
intercellular communication, but the mechanisms underlying EV biogenesis in Gram-positive bacteria are poorly
understood. S. aureus EVs encapsulate cargo that includes surface adhesins, lipoproteins, capsular
polysaccharides, and exoproteins, including proteases and pore-forming toxins, which have been shown to play
roles in bacterial virulence and the transmission of biologic signals to host cells. The overall goal of this project
is to gain a better understanding of the biological role that S. aureus EVs play in the pathogenesis of
staphylococcal infections. The project hypothesis is that EVs modulate bacterial pathogenesis by serving as a
novel secretory pathway for S. aureus to transport toxins, cytoplasmic proteins, and lipoproteins and deliver them
into host cells, while protecting the cargo from detection or destruction by the external environment. Preliminary
data indicate that S. aureus EVs package an array of virulence factors, are taken up by macrophages, and are
cytotoxic for a variety of host cells. Moreover, S. aureus EVs induce cleavage of caspase-1 and release of mature
IL-1β and IL-18 in human macrophages in a lipoprotein-dependent manner. These results highlight the role of
EVs in inflammasome activation, an important intracellular immune pathway that has been shown to play a
crucial role in determining the outcome of S. aureus infections. Specific mechanisms whereby EVs are generated
and the downstream effects of EV release from the bacterial cell are goals of this proposal. The specific aims of
this application are to: (1) elucidate the mechanisms underlying EV biogenesis in S. aureus and the role of EVs
in the SA cellular release of cytoplasmic proteins, lipoproteins, and capsule; (2) determine whether EVs act as a
transport mechanism to deliver S. aureus virulence factors into host cells; and (3) investigate EV-induced
inflammasome activation and its biological role in S. aureus infections. To accomplish these goals, a
multidisciplinary approach will be taken that combines genetics, molecular biology, cell biology, immunology,
electron microscopy, biochemistry, and animal infection models. These efforts are essential for gaining a
functional appreciation of the role that S. aureus EVs play in the host-pathogen interaction. The knowledge
obtained from this study will deepen our currently limited understanding of microbial EVs and have broad
implications for our understanding of the pathogenesis of Gram-positive pathogens.

Public health relevance
Project Narrative Staphylococcus aureus produces nano-sized, spherical, bilayered, extracellular membrane vesicles (EVs) that serve as a novel secretory pathway for S. aureus to transport toxins, cytoplasmic proteins, and lipoproteins into mammalian host cells. This project will characterize the generation of EVs by S. aureus, investigate their uptake by host cells, and describe the host inflammatory response to EVs. Elucidation of the mechanisms of EV-induced inflammasome activation may reveal novel aspects of the host-pathogen interaction that could lead to new strategies for treating S. aureus disease.